Mechano-niche in Lung Repair after Injury

Normal structure and function of the lung is maintained in homeostasis and repaired/regenerated following
diverse injuries by regionally defined stem/progenitor cells. Stem cells reside in unique tissue
microenvironments, known as the stem cell “niche”, which constitutes stem cell progeny, other niche-support
cells including mesenchymal cells (MCs), and the surrounding extracellular matrix (ECM). The stem cell niche
provides instructive cues for stem cell self-renewal and differentiation. Fibrotic lungs undergo substantial
changes in the tissue biomechanical properties, manifested by stiffening of the ECM. Cells residing in the stem
cell niche sense and respond to alterations in the stiffness of the microenvironment, highlighting matrix
stiffness as an important mechanical component of the stem cell niche. In preliminary studies, we have
characterized the stiffness of alveolar type 2 epithelial stem cell (AT2) niche associated with Pdgfrα+ lung MCs.
Alveolar organoid culture in newly developed, stiffness-tunable 3D hydrogels demonstrated that matrix
stiffness constitutes an AT2 niche. We recently identified that α6-integrin is a mechanosensitive integrin
subunit; stiff matrix-induced α6 expression, primarily an α6 isoform with a shorter cytoplasmic domain (α6S),
mediates lung fibroblast invasion into the basement membrane. New preliminary data now show that in
addition to α6 expression, matrix stiffness regulates alternative splicing of α6 pre-mRNA in Pdgfrα+ lung MCs,
resulting in differential expression of a distinct α6 isoform with a longer cytoplasmic domain (α6L) under soft
/homeostatic matrix conditions and a switch from α6L to α6S predominance under stiff/fibrotic matrix
conditions. We found that α6L expression promotes lipogenic differentiation of lung MCs and confers the AT2-
niche function, facilitating reinstatement of lung homeostasis. In contrast, α6S expression impairs the AT2-
niche function and promotes fibrogenic/invasive differentiation of lung MCs, contributing to lung fibrosis. In this
proposal, we hypothesize that matrix stiffness-dependent alternative splicing of α6-integrin regulates the repair
of injured lungs by controlling alveolotrophic vs. fibrogenic differentiation of lung mesenchymal cells. Specific
aims in the proposed study are: (1) determination of the mechanisms by which matrix stiffness regulates
alternative splicing of α6-integrin; (2) determination of the mechanisms by which distinct α6-integrin
cytoplasmic variants mediate alveolotrophic vs. fibrogenic differentiation of lung mesenchymal cells; and (3)
testing the potential of targeting matrix stiffness-dependent alternative splicing of α6-integrin for the reversal of
sustained pulmonary fibrosis in mice. Understanding the mechanisms by which lung epithelial stem cells
interact with their niches in normal vs. pathological repair of the injured lung will provide novel therapeutic
approaches to prevent, treat, and potentially reverse pulmonary fibrosis.

Public health relevance
Idiopathic pulmonary fibrosis (IPF) is the most common and lethal form of the fibrotic lung diseases that is associated with loss/dysfunction of lung stem cells. The proposed study aimed to explore the molecular mechanisms by which stem cells are dysregulated in lung fibrosis. The ultimate goal of this work is to provide new interventions and therapeutic approaches to prevent, treat, and potentially reverse fibrotic lung diseases.